Core B

PROJECT SUMMARY/ABSTRACT: CORE B
The Clinical Core (Core B) will be responsible for providing the human tissues necessary for completion of
the Aims of Projects 1–3 and the Human Validation Core (Core C). The availability of tissues from ALS
patients and controls is essential for better defining the relevance of data generated from animal and in vitro
disease models. With a focus on ALS related to the C9orf72 hexanucleotide repeat expansion (c9ALS), Core
B will collect, bank and distribute cerebral spinal fluid (CSF), skin and/or blood samples for induced pluripotent
stem (iPS) cell generation, and postmortem tissue from deeply phenotyped c9ALS patients, as well as patients
with sporadic ALS (sALS). Importantly, to investigate changes in biomarkers that reflect the transition from the
presymatomatic to the symptomatic phase of disease, we will seek out asymptomatic carriers of the C9orf72
repeat expansion, identified from family members of c9ALS patients, to be followed longitudinally. We will also
pursue postmortem tissue collections from patients who were studied during life, which will allow for the high
value comparison of data from brain and spinal cord tissue with spinal fluid and iPS cells. In addition to new
patients and samples generated during the course of this P01 program project, Core B will act as the
“clearinghouse” for samples already banked at our respective institutions (Emory, Mayo Clinic Jacksonville,
Massachusetts General Hospital, and Johns Hopkins), and from our collaborators at the NIH and the Target
ALS Foundation. Core B will maintain a database of available tissues for distribution to Project and Core
investigators. Project PIs will request biofluids and tissue samples from Core B, and Core B will identify
appropriate sources and facilitate sample shipments. Note that each participating institution retains its own
IRB-approved protocols for collecting patient data and biological samples, and banks all biospecimens locally.
Thus, Core B will act as a central coordination core that will maintain a database and arrange for distribution of
patient tissue samples at each institution.